Decoding host-pathogen crosstalk that drives intracellular niche formation during Salmonella infection

PROJECT SUMMARY
Of the foodborne pathogens, non-typhoidal Salmonella enterica (NTS) cause the largest burden of illness and
death worldwide. Upon entering the gut, Salmonella can traverse the mucosal barrier by inducing its uptake into
intestinal epithelial cells, followed by growth in lamina propria phagocytes. In recent years, it has been
discovered that intracellular Salmonella could colonize two niches in host cells – within a membrane-bound
vacuole and free in the cytosol – with profound consequences on host cell death and bacterial survival strategies.
But our understanding of these parallel intracellular colonization strategies is currently limited by approaches
that are not suited to untangle bacterial and host factors in subpopulations of infected cells. In the proposed
work, we will study intracellular niches of Salmonella enterica serovar Typhimurium within human intestinal
epithelial cells and macrophages. Combining a sensitive bacterial fluorescent reporter, fluorescence-assisted
cell sorting (FACS) and dual RNA-seq methods, we will analyze cell type-specific bacterial and host transcripts
from subpopulations of infected cells that contain cytosolic vs. vacuolar bacteria. We will characterize bacterial
and host transcripts during Salmonella infection of intestinal epithelial cells, distinguishing between cytosolic vs.
vacuolar phenotypes (Aim 1.1). In parallel, we will characterize Salmonella infection of macrophages (Aim 1.2).
Combining dual RNA-seq of sorted populations and bioinformatics, we will use genetic perturbations to test the
contribution of bacterial and host gene candidates to the intracellular localization phenotypes (Aim 1.3). By
defining niche-specific and host cell type-specific interaction networks, we can pinpoint the most crucial
vulnerabilities of S.Tm during infection of human hosts.

Public health relevance
PROJECT NARRATIVE One way to treat infections is to harness the host immune system to fight infection or target virulence processes of the pathogen. To do so, we require a much better understanding of the molecular interactions between the bacteria and host cells that drive infection outcome. Here, we will use complementary approaches that will allow us to correlate gene expression changes of bacteria and infected host cells, coupled with analysis of the phenotypic intracellular localization of the invading bacteria. This combined approach will provide us with a clear interpretation of host and bacterial genes and pathways that determine the outcome of a host-pathogen interaction.